University of MIami Neurosurgery eDucation Strategy UMINDS

Project Summary
The University of MIami Neurosurgery eDucation Strategy (UMINDS) over-arching goal is to
foster the development of research scientists in our program and help prepare them for a career
as an independent NIH funded researcher. The proposed program leverages university wide
initiatives in neuroscience and neurobiology to form an interdisciplinary group of mentors from
multiple departments at the University of Miami. The program will be led by a group of clinician
scientists with a rich track record of resident education and independent neurosurgical funding
(Allan D. Levi, MD PhD; Malcolm R. Bullock, MD, PhD; and Dalton Dietrich, PhD). The principal
investigators selected diverse and extremely qualified mentors that will elevate the scientific and
clinical skillsets of our resident cohort. In order to accommodate the wide range of resident
research interests, we have created two separate research education tracks: basic/translational
science and health outcomes/disparities. The latter will focus on understanding and correcting
health disparities in neurosurgery by combining genomic, epidemiologic, and clinical research.
The present proposal will help transition neurosurgery residents into junior faculty positions and
facilitate the acquisition of independent career development awards (K-equivalent or greater). The
goals of our program are 1) to create an avenue for residents to maintain robust research
throughout their residency; 2) to fully prepare neurosurgery residents for careers as independent
surgeon-scientists; 3) to enhance our trainees’ ability to attain research funding; 4) and to
generate high quality research that will ultimately improve health outcomes and scientific
knowledge in our diverse community. By providing mentorship, structure and infrastructural
support, the UMINDS unique training program will certainly augment the research education and
future careers of our neurosurgery trainees.

Public health relevance
PROJECT NARRATIVE Our program aims to provide neurosurgery residents with the opportunity to engage in significant structured research during their residency by coupling residents with established productive mentors. Our trainees will be supported throughout their research project from conception to publication, eventually facilitating their transition to junior faculty positions with dedicated NIH funding (K-or R equivalent). The University of MIami Neurosurgery eDucation Strategy (UMINDS) will foster the development of research scientists in our program and prepare them for careers as independent NIH funded researchers.